Is Chromosome Therapy Possible for Down Syndrome and Other Karyotypic Imbalances?

[unreadable] [unreadable] [unreadable] [unreadable]

Public health relevance
Lay summary: This proposal would test a wholly new approach to a possible genetic therapy for chromosomal trisomy, for which gene therapy is not currently considered feasible. We would assess the feasibility of silencing the extra chr 21 in human DS cells and in a mouse DS model using the system nature uses to silence one X chr. in females.